Cholinergic interneuron regulation of opioid-related behaviors

Project Summary
Opioid use disorder (OUD) is a debilitating and life-long addictive disease with significant public health
costs. OUD is characterized by various symptoms, including a compulsive need to use, loss of control over
use, and a negative emotional state induced by withdrawal. Mu-opioid receptors (MORs) in the ventral
tegmental area (VTA) are known to contribute to both the rewarding effects of opioid use and the aversive
signs and symptoms of opioid withdrawal. However, there is growing evidence that additional populations of
MOR, which is broadly expressed throughout emotional and motivational brain circuits, critically contribute to
opioid-related behaviors. Striatal cholinergic interneurons (CINs) regulate dopamine release and responding
for rewards. Given these important functions of CINs, and because this neuronal subpopulation expresses
MOR, we hypothesize that MOR stimulation alters CIN activity and striatal dopamine release to promote opioid
reward, consumption, and withdrawal-induced aversion. Our experiments will test this hypothesis through
completion of two primary specific aims. We will determine 1) whether MORs on cholinergic interneurons
participate in opioid reward and withdrawal and 2) whether CIN MORs regulate dopamine release during opioid
reward and withdrawal. Opioid reward will be tested using a conditioned place preference (CPP) task and
withdrawal using conditioned place aversion (CPA). Opioid consumption will be assessed with a limited
access, two-bottle choice fentanyl drinking task developed in our lab. Collectively, completion of these aims will
demonstrate that MORs on NAc CINs contribute to opioid reward, consumption, and withdrawal through
modulation of DA release. Furthermore, we will train undergraduate students in a broad array of modern
behavioral neuroscience techniques, such as chemogenetics, fluorescent in situ hybridization, and
fluorophotometry. These activities will expand access to meaningful research opportunities to a diverse set of
talented undergraduate students interested in neuroscience and other biomedical research fields at Miami
University.

Public health relevance
Project Narrative The positive emotional affects of opioid use and negative emotional effects of withdrawal contribute to the development of Opioid Use Disorder, which accounts for tens of thousands of deaths in the United States each year. This project will use mouse models of morphine reward, fentanyl consumption, and naloxone-precipitated withdrawal to investigate how mu-opioid receptors on a subpopulation of neurons in the nucleus accumbens promote opioid reward and aversion. Understanding the neural mechanisms responsible for Opioid Use Disorder will inform future therapies and treatments for the disease.